Modulation of Insulin Signaling in Adipocytes

Modulation of Insulin Signaling in Adipocytes
Adipose tissue is essential for normal energy homeostasis. It exerts important anti-lipotoxic effects by
neutralizing free fatty acids after nutrient absorption and by releasing them through lipolysis upon systemic
demand. It has been established that a dysfunctional adipocyte is tightly linked to metabolic challenges in other
tissues. Aberrant insulin signaling, as observed in insulin resistance at the level of the adipocyte, is a key driver
of systemic metabolic dysfunction. Our key hypothesis is that any intervention that aims to alleviate
aspects of systemic metabolic dysfunction critically relies on an improvement in the insulin sensitivity
of the adipocyte. How does improved adipocyte insulin sensitivity contribute to positive metabolic outcomes?
We identified a number of gaps in our knowledge regarding insulin signaling in the adipocyte. We will take
advantage of a multipronged approach to finetune the insulin response selectively in the adipocyte.
We will deploy diverse tools to investigate the contribution of adipocyte insulin signaling to a new paradigm of
insulinopenic insulin sensitization and to the effects of modern incretin and glucagon receptor agonists. We will
address these questions at the cellular, tissue, and systemic level with the following Specific Aims:
In Aim 1, we propose to carefully titrate insulin signaling within the adipocyte by i) inducible reduction
of insulin receptor expression, ii) selective activation of an artificial insulin receptor, or iii)
manipulation of the insulin signaling modulator PTEN. Many of these approaches will take advantage of
recently developed models that were not previously available to the field. In Aim 2, we plan to define the
consequences of a targeted reduction in β-cell insulin release on the adipocyte by i) controlled
suppression of membrane depolarization or ii) induction of progressive mitochondrial dysfunction. Our
new β-KIR6.2V59M and β-mitoKiller mouse models use a mouse insulin 1 promoter-based driver to achieve β-
cell-specific and inducible transgene expression. In β-KIR6.2V59M mice, an activating mutant KATP channel
subunit is used to suppress membrane depolarization, which, upon mild induction, results in reduced glucose-
stimulated insulin secretion (GSIS) without hyperglycemia. These mice retain insulin sensitivity upon exposure
to a high-fat diet. In β-mitoKiller mice, a viral protein is employed that specifically degrades mitochondrial DNA,
causing mitochondrial dysfunction. This results in a lack of GSIS, progressive hyperglycemia, and deteriorated
glucose tolerance while basal insulin levels are maintained. We will specifically examine the role of altered
adipocyte insulin signaling in these two unique models. In Aim 3, we will determine the contribution of
adipocyte insulin signaling to the beneficial effects of GLP1-R+GIP-R and GLP-1R+GIP-R+GCG-R
agonists. Does increased adipocyte insulin responsiveness contribute to the effects of these drugs on weight
loss and systemic metabolism? Does an insulin-resistant adipocyte prevent such improvements? Combined,
our studies should provide new insights into the physiological contributions of the insulin-sensitive adipocyte.

Public health relevance
A functional adipocyte is one of the key contributors to systemic metabolic health. For the adipocyte to unfold its full metabolic potential, it needs to be fully insulin-sensitive. While much work has gone into defining insulin signaling in the adipocyte, many important gaps remain. Here, we propose to focus specifically on insulin receptor and post-receptor manipulations selectively in the adipocyte. Using a series of novel adipocyte-specific and inducible manipulations to enhance or reduce insulin sensitivity, we assess whether the adipocyte insulin response contributes towards systemic improvements in the context of enhanced insulin sensitivity brought about by limiting excessive insulin excursions initiated by the pancreas and in the context of insulin sensitization through novel single, dual and triple incretin responses. Results from the proposed experiments should lead to a better mechanistic understanding of how adipocyte insulin sensitivity contributes to systemic metabolic improvements.